Health and Retirement Study: Harmonized Cognitive Assessment Protocol (HCAP)

PROJECT SUMMARY/ABSTRACT
The primary aim of the Health and Retirement Study (HRS) cooperative agreement is to collect and
distribute multi-disciplinary data to support research on aging. Cognitive impairment and dementia, including
Alzheimer's disease and Alzheimer's disease related dementias (AD/ADRD), impose enormous burdens on
families and government policies. To provide the research community with new and richer data to study the
prevalence, predictors, and outcomes of cognitive impairment and dementia, we undertook the HRS
Harmonized Cognitive Assessment Protocol (HCAP) Study during the HRS 2016 field period, in which we
administered a supplemental in-home 1-hour battery of cognitive tests to about 3,200 randomly selected and
nationally representative HRS respondents aged 65+, as well as a 20-minute informant interview. In the
proposed HCAP 2020 follow-up study, we will re-administer the same HCAP in-home cognitive assessment
and informant report to all surviving members of the original HCAP sample (n ~ 2,250), and to a new random
sample of those aged 65 to 68 in 2020 (n ~ 720). The HCAP 2020 follow-up study will provide extensive new
data to better assess trajectories of cognitive decline among older US adults, including the incidence of new
cognitive impairment and dementia. These data will also provide an unprecedented opportunity to better
understand trends in the incidence and prevalence of dementia in the US and around the world.

Public health relevance
PROJECT NARRATIVE This proposal aims to conduct a follow-up to the 2016 Health and Retirement Study (HRS) Harmonized Cognitive Assessment Protocol (HCAP) sub-study by re-administering in 2020 the same HCAP in-home cognitive assessment and informant report to all surviving members of the original HCAP sub-sample of HRS participants (n ~ 2,250), and to a new random sample of HRS participants aged 65 to 68 in 2020 (n ~ 720). The HCAP 2020 follow-up study will provide extensive new data to support research on the causes, consequences, and trends of cognitive impairment and dementia in the US and around the world.